Emergence of bedaquiline, pretomanid and linezolid resistance after implementation of new drug-resistant tuberculosis regimens in South Africa

PROJECT SUMMARY
Drug-resistant (DR) tuberculosis (TB) threatens to derail the progress made in global control of TB and
HIV. Of the nearly 500,000 new cases of multidrug-resistant (MDR) TB worldwide annually, only half are cured
and those with extensively drug-resistant (XDR) TB have even poorer outcomes. New and repurposed drugs
for TB have revolutionized MDR/XDR TB treatment, resulting in improved cure rates and shorter, fully-oral
regimens. Bedaquiline (Bdq) and pretomanid (Pa) are medications from the first novel TB drug classes created
since 1968. Combined with a repurposed medication, linezolid (Lzd), these new drugs have provided
substantial improvements in survival and cure rates. The emergence of widespread Bdq, Pa or Lzd resistance
could undermine these drugs’ potential. The natural history of drug resistance is conceptualized as evolving
from sporadic drug-resistant mutants with low-level resistance soon after the drug is introduced, to a few highly
adapted transmissible strains that spread resistance across a population in a mature DR TB epidemic. As seen
in MDR/XDR TB, population-level drug resistance appears only after widespread transmission of drug-resistant
strains occurs, rather than through isolated instances of acquired resistance on TB treatment. In the proposed
study, we will examine the emergence of Bdq, Pa, and Lzd resistance in South Africa as treatment with these
new drugs is expanded to all drug-resistant TB cases. In Aim 1, we will prospectively characterize changes in
resistance-conferring mutations for Bdq, Pa and Lzd using whole genome sequencing (WGS) on isolates from
patients in three provinces. In Aim 2, we will examine minimum inhibitory concentrations (MIC) to assess for
meaningful shifts in the level of resistance to Bdq, Pa, and Lzd over the course of the study. In Aim 3, we will
use WGS, prior treatment exposure, and geospatial analysis to identify increased transmissibility and
geographic spread of Bdq, Pa, and Lzd resistance. The proposed study will provide essential information that
can inform the development of new rapid diagnostic assays for these critical new TB drugs. Further, our
phenotypic analyses will inform decisions on whether it is necessary to add drugs to existing treatment
regimens or increase the dose of a specific medication. Finally, our analyses of genetic clonality and
geographic spread will provide early warning signs to TB control programs about the potential for widespread
transmitted resistance. South Africa serves as a bellwether for the emergence and spread of DR TB. It is a
high-burden country that is leading the global scale up of new treatment regimens containing Bdq, Lzd, and
now Pa, for all drug-resistant patients. The proposed study is optimally timed to prospectively study the
emergence, evolution and dispersal of drug resistance to Bdq, Pa and Lzd as they are being scaled up for the
DR TB treatment worldwide.

Public health relevance
PROJECT NARRATIVE Bedaquiline and pretomanid are medications from the first new antibiotic classes approved for tuberculosis (TB) by the FDA in 40 years; linezolid was originally developed to treat Gram-positive bacteria but has been found to be effective against TB. Combination treatment regimens using these new drugs have transformed the treatment of drug-resistant TB; however, emergence of resistance to these drugs would undermine the utility of these treatment regimens. We will utilize genomic sequencing, microbiologic and geospatial data, to study the emergence and expansion of resistance to bedaquiline, pretomanid and linezolid in South Africa; this study will provide information that is vital for preserving the effectiveness and ensuring the successful global scale-up of these lifesaving treatment regimens.